2025 Vascular Cell Biology Gordon Research Conference and Gordon Research Seminar

Project Summary
This Gordon Research Conference (GRC), “Vascular Cell Biology”, and the accompanying Gordon Research
Seminar (GRS, organized by and for trainees) of the same name have the overarching hypothesis that gaining
a better understanding of how endothelial and mural cell (smooth muscle cell, pericyte) phenotypes are
established and maintained to enable proper vascular function in distinct tissue environments is important basic
knowledge that is crucial for preventing disease progression and promoting vascular repair and regeneration.
The goals of this GRC/GRS are to bridge existing knowledge and communication gaps between researchers at
all levels (students, postdocs, junior and senior scientists) in academia, industry and government who study
vascular cell biology and those who study vascular disease, bioimaging, genomics and other related areas.
These fields have recently developed paradigms, tools and models to aid this goal, and this integration is
predicted to move all fields forward towards timely translation of basic discoveries. This GRC will strongly foster
lasting interdisciplinary interactions and collaborations amongst NIH-funded and international vascular cell
biologists, between academic, industry and government scientists, and development of the next cadre of
scientists at the intersection of these fields by exposure to new ideas, issues and opportunities. The associated
GRS will also support these goals with an emphasis on trainee development. The GRC Chair and vice-Chair are
leaders in the vascular biology field and well-suited to organize the meeting. The meeting goals will be
accomplished by bringing together a selected group of researchers (about 150 participants) to a small, semi-
isolated site (in Ventura, California) for a week, in a venue and meeting structure designed to foster extensive
discussion after presentation of largely unpublished data, and to promote informal interactions and networking
through shared meals and afternoon social activities that especially benefit trainees. Invited speakers and
discussion leaders are chosen based on excellence in research and willingness to engage trainees. Participants
will be chosen based on topic and demographics. Female, early/mid-career stage and minority speakers have
been invited, and those groups will be encouraged to apply as participants. A GRS pre-meeting will be organized
by trainees, for trainees (with limited input from GRC chairs and GRS faculty mentors), and feature presentation
of trainee work, to facilitate networking among this group and provide them with a peer group as they transition
into the larger meeting. This GRC/GRS meeting will have a strong and lasting impact on the field, as it addresses
important basic questions and health issues in vascular biology at a propitious time.

Public health relevance
Project Narrative The Gordon Research Conference on Vascular Cell Biology will promote new knowledge integrating basic mechanisms of endothelial and mural cell heterogeneity with regulation of tissue development, function, repair, and regeneration. This is a relatively small meeting with about 150 attendees that is designed to foster networking and discussion, exchange of new unpublished data and ideas, and to jump-start collaborations that will move the field forward. An associated Gordon Research Seminar, organized by and for trainees, will encourage the next corps of interdisciplinary vascular biologists to innovate and rejuvenate the field; this two-pronged approach will allow researchers to focus on important basic science questions and tackle urgent health issues in vascular biology.